Novel Host-Response Biomarker Diagnostics for Invasive Aspergillosis

PROJECT SUMMARY/ABSTRACT
Invasive aspergillosis (IA) is a severe and frequent complication in immunocompromised patients. Earlier
diagnosis expedites appropriate antifungal therapy and drastically improves clinical outcomes and patient
survival. However, current pathogen-based fungal testing is often hampered by poor accuracy, delayed results,
and a requirement for invasive sampling. This proposal will overcome these limitations by establishing novel,
rapid, noninvasive diagnostic and prognostic biomarkers for IA based on host transcriptional responses to
infection. Moreover, the project will ensure that these biomarkers can accurately function in the presence of
diverse immunosuppressive regimens. Building on the candidate’s published work, the main goals of this project
are three-fold: 1.) To derive and optimize a diagnostic host gene expression signature of IA from banked samples
of a large established repository; 2.) To enroll and serially sample subjects with fungal infection to derive a
prognostic host gene expression signature of IA and measure response to treatment; and 3.) To develop the
candidate into a uniquely qualified independent translational physician-scientist, advancing non-invasive
diagnostic and precision medicine tools for infection in immunocompromised patients. This research is critical
for NIAID’s mission to better understand and treat fungal infections, particularly as Aspergillus species have
become increasingly recognized as critical fungal pathogens. Additionally, the project will develop the candidate’s
expertise in biological pathway analysis and fungal immunology, diagnostic test development and evaluation,
and biomarker implementation. The results of this project will also generate preliminary data for the next step in
this program of research, progressing through the translational pathway to develop and implement a clinically
validated host-based diagnostic and prognostic tool for IA. The candidate’s research and career development
will be guided by an invested and experienced mentorship team at a research-intensive institution with abundant
resources in infectious diseases, translational research, transplantation, genomics, and precision medicine.

Public health relevance
PROJECT NARRATIVE Fungal infections due to invasive aspergillosis cause severe illness and death in people with weakened immune systems, but despite medical advances, we lack rapid, accurate, noninvasive tests to diagnose these devastating diseases. The proposed research will develop novel host-based testing approaches for invasive aspergillosis diagnosis and response to treatment. The results from this research will lead to earlier initiation of appropriate antifungal therapy, thus improving clinical outcomes for vulnerable patients.